Core A: Viral Vector and Transgenic Mouse Core

The overall objective of the Viral Vector and Transgenic Mouse Core is to provide Diabetes Research Center affiliate investigators at the University of Washington with state-of-the-art vectors necessary to overexpress, knockdown, knockout, or otherwise alter expression of RNAs and proteins of interest in cultured cells, isolated fissues, and animals. The Core has considerably evolved since the last competifive renewal. New services to generate genetically engineered mice have been added, and under-ufilized and standard molecular biology methods that are now increasingly performed in individual investigator's labs have been removed. The specific aims of the Core are to provide the following services to affiliate invesfigators: (1) Producfion of lentiviral, adenoviral and retroviral vectors for use in animals, fissues, and cells; (2) Producfion of vectors for generation of transgenic, knockout, and knockin mice; (3) Specialized molecular biology methods not routinely performed in affiliate investigators' laboratories; (4) Cost-effective production of genefically engineered mice through the University of Washington Transgenic Resources Program; and (5) Consultafion and training.. The Core has been highly productive in the current funding period and has added new services that are expected to significantly increase producfivity and usability for Diabetes Research Center affiliate investigators to meet the Center's goal to enhance research in diabetes, obesity and related disorders in the Greater Seattle area and beyond. RELEVANCE

Public health relevance
RELEVANCE A cornerstone of diabetes research is the use of viral vectors to modify expression of specific proteins and genetically engineered mice for the study of diabetes pathogenesis, treatment strategies, and diabetic complications. The services provided by the Viral Vector and Transgenic Mouse Core fulfill this need.